ITRACONAZOLE FOR PRIMARY TREATMENT OF DISSEMINATED HISTOPLASMOSIS IN AIDS

This multicentric study will examine the usefulness of itraconazole as the primary therapy for disseminated histoplasmosis in patients with AIDS. Subjects will be given a loading dose of itraconazole followed by maintenance therapy extending up to 64 weeks.